Center of Biomedical Research Excellence in Acute Care Research and Rural Disparities

Project Summary
Cardiac arrest has both a high incidence and high rate of mortality, with less than 7% of patients achieving a
good neurological outcome. Patients that demonstrate alterations to glucose metabolism, a potential treatment
target, have the lowest survival rates after resuscitation. The parent award for this study seeks to define how
molecular heterogeneity and cellular disturbances after cardiac arrest affect post-resuscitation outcomes.
Conversely, this study will focus on the regulation of glucose metabolism, which relates to immunological
function, yet provides independent therapeutic opportunities. Recently, a great deal of interest has centered
on the metabolic capacity of brown fat in humans, as this tissue has a high capacity for oxidizing metabolic
fuels like glucose. Brown adipose tissue is activated by cold exposure, and standard guidelines-based
treatment for cardiac arrest includes therapeutic hypothermia. Brown adipose tissue is activated in cardiac
arrest patients, and optimal regulation of circulating glucose levels is unknown. Brown adipose tissue can be
measured by quantifying a circulating lipid called 12,13-diHOME, and our preliminary studies show that
patients harboring certain genetic variants have abnormal levels of 12,13-diHOME and blood glucose. We
seek to determine whether brown adipose tissue plays a role in regulating glucose metabolism after cardiac
arrest, and the studies we propose will dovetail with work in the parent award to improve outcomes in these
patients. To this end we propose an innovative approach wherein we measure 12,13-diHOME levels in
cardiac arrest patients with and without a single nucleotide polymorphism (SNP) that we and others have
identified in the gene EPHX2, which codes for the 12,13-diHOME biosynthetic enzyme. Our proposed work
benefits from a team science effort because we bring together unique expertise in the areas of post-
resuscitation cardiac arrest care (Seder) and brown adipose tissue biology (Lynes). Dr. Seder has over twenty
years of experience treating cardiac arrest patients, and Dr Lynes likewise has over 15 years of experience
studying brown adipose tissue biology in animal models and patient samples. Dr. Seder’s experience in
isolating clinical and molecular variables that could benefit our analysis will be highly valuable. Dr. Lynes
originally identified the biomarker that we propose to measure, 12,13-diHOME, and has published a wide
range of studies on this lipid. Our research also benefits from a team science approach because it seeks to
span the full gamut from a patient’s DNA to their circulating metabolites and all the way to their phenotypic
outcome, so we require a full team of researchers who can interact with patients, perform sample collection,
data collection, data analysis and interpretation of results. This starts with our unique access to patients and
initial specimen procurement and processing through Dr. Seder, followed by glucose and lipid measurement
and analysis by Dr Lynes – their collaboration facilitating each step of this process. The completion of this
study will define discrete patient subpopulations that benefit from therapeutic hypothermia after cardiac arrest,
and identify a novel tissue target to mitigate post arrest alterations to glycemia, ultimately improving outcomes.

Public health relevance
Narrative Determining if the lipokine 12,13-diHOME mediates an interaction between the gene EPHX2 and survival after cardiac arrest relates to human health because the results could identify subjects who may benefit from increasing 12,13-diHOME to mitigate post-arrest hyperglycemia. In generating preliminary data, we have validated the finding that 12,13-diHOME in humans is increased after cardiac arrest and identified a polymorphism in EPHX2 that correlates with blood glucose levels. By completing the studies in this proposal, we hope to determine if the level of 12,13-diHOME mediates the effect of EPHX2 genotype on blood glucose.